Molecular basis of fatty acid transport by peroxisomal ABC transporters

Project Summary
Peroxisomal ABC transporters like ABCD1, ABCD2, and ABCD3 shuttle very long chain fatty acids (VLCFAs),
branched chain fatty acids (BCFAs), and bile acid precursors into peroxisomes. Their functional impairment leads
to severe neurological and metabolic pathologies stemming from disrupted phospholipid and fatty acid
metabolism, including X-linked Adrenoleukodystrophy (X-ALD), both the most common leukodystrophy and most
common peroxisomal disorder that is caused by mutations in ABCD1 and for which no cure exists, and bile acid
synthesis defects and liver disease stemming from impaired ABCD3 function. While additional roles for ABCD
transporters in a wider array of disease pathways continue to be uncovered, the underlying mechanisms
governing their substrate recognition, transport, and transport regulation remain poorly understood. The long-
term objectives of this project are to gain insight into peroxisomal ABCD transporter function and regulation in
molecular detail. We will use a combination of biochemical and cell biological tools, high resolution structural
analysis by cryo-electron microscopy, and continuous wave electron paramagnetic resonance (CW-EPR)
spectroscopy to reveal the functionally relevant structural features and conformational states used by ABCD
transporters in fatty acid translocation, how they may be altered by ABCD1 mutation in X-ALD, and how ABCD1
is mechanistically distinct from ABCD2 and ABCD3 despite their functional overlap. Specific Aim 1 deals with
the development and utilization of in vitro assays for determining substrate specificity profiles and transport
properties of ABCD1, ABCD2, and ABCD3. Specific Aim 2 deals with obtaining high resolution structural
information of ABCD1, ABCD2, and ABCD3 in functionally relevant states in a physiological lipid environment
through cryo-EM analysis. Specific Aim 3 deals obtaining information on the structural dynamics of ABCD1
through CW-EPR studies. Our results will provide fundamental insights into peroxisomal ABC transporter
functioning that can be exploited for ABCD1 targeted diagnostic and therapeutic tools to improve X-ALD patient
outcomes, provide a framework for the design and development of chemical probes to study ABCD family
function, and generate reliable in vitro and in silico tools to accelerate drug development/discovery efforts
targeting them.

Public health relevance
Project Narrative Impaired function of ATP Binding Cassette transporters of the D subfamily underlies a wide array of serious metabolic and neurological diseases such as X-linked Adrenoleukodystrophy, a rare genetic disorder caused by mutations in ABCD1 that can be fatal and for which no cure exists, and other defects caused by impaired fatty acid and phospholipid processing. This project focuses on detailed structure-function studies on the peroxisomal fatty acid transporters ABCD1, ABCD2, and ACBD3 to understand how they work at the molecular level to aid in future design and development of diagnostic and therapeutic tools to combat diseases stemming from their dysfunction.